Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core of the Population Research Center (PRC) is the infrastructure that supports the
activities of the other Cores and that facilitates all population dynamics research activities. The overarching
goal of the experienced Administrative Core is to provide dependable yet flexible services that enable the
conduct of cutting-edge population sciences research by PRC faculty scholars. The activities of the
Administrative Core are organized around four aims. Aim 1 is to promote the exchange of ideas that will
accelerate the next generation of population sciences breakthroughs. Activities include the Visiting Scholars
Program, the Friday Seminar Series, First Friday Lunches, a weekly newsletter, and a training program. Aim 2
is to develop collaborations with the new TEXPOP Network of external faculty affiliates from universities across
Texas. The annual TEXPOP Conference will serve as a means to foster exchange and collaboration among
PRC faculty scholars and external faculty affiliates. Aim 3 is to reduce administrative burdens for PRC faculty
scholars through the provision of comprehensive financial and project management. Aim 4 is to disseminate
the findings from PRC faculty scholars’ research, primarily through its Research Briefs series. The 1:9 ratio of
Core staff to faculty scholars allows for the timely and efficient provision of services to meet Core Aims. Every
PRC faculty scholar uses the Core’s services in order to advance their innovative population dynamics
research.